MAPPING CHROMOSOME 11 IN PIMA INDIANS

Chromosome 11 contains several candidate genes that may be involved in the etiology of insulin resistance and type II diabetes. These candidate genes include the insulin gene, protein phosphatase 1 alpha, glycogen phosphorylase, c-Ha-ras, and IGF-2. In an effort to search for chromosomal regions and subsequently the genes involved in insulin resistance and type II diabetes polymorphic markers are being used to examine chromosome 11 at a 10 centimorgan resolution.